Gene Coexpression Network Regulating Repetitive Behavior under Nutritional Change.

Stereotypic repetitive behaviors, which are thought to be an obstacle to complex task execution,
including social behaviors and learning, are observed in mammalians and fish. Animals exposed to stress-
associated environment frequently exhibit repetitive behaviors. Chronic stress is known to change the
neurocircuit property and increase the blood glucose level. Accordingly, the low-carbohydrate ketogenic diet
reduced repetitive behaviors in disorder model animals. However, there is a significant knowledge gap
regarding how repetitive behaviors are particularly selected among other voluntary behaviors; is it based on
neurocircuit and/or metabolic changes? Whether natural genetic variations promote an increase or decrease
in repetitive behavior level is also poorly understood. Consequently, our central hypothesis is that, in an
experimental system relevant to typical heterogeneity, nutritional ketosis reduces repetitive behavior by
modifying the known dopaminergic and GABAergic signaling that choose the behavior modules (e.g.,
repetitive behavior, mating behavior, etc.). To provide the foundation to test this hypothesis, this project’s
main objective is to identify the gene coexpression regulatory network and its hub genes that reduce
repetitive behavior under ketosis. The Mexican teleost fish Astyanax mexicanus will be strategically chosen
as an experimental model, which consists of cave-dwelling (cavefish) and surface-dwelling fish (surface fish).
The cavefish display asocial behaviors and exhibit 1,839 of the shared directional gene expression changes
seen in human disorders related to repetitive behavior. This project’s rationale is that the genetic and
environmental impacts on repetitive behavior with the naturalistic heterogeneity are easy to study on our
animal platform, yielding the basic knowledge for neuronal and cellular responses to ketosis associated with
repetitive behavior. The research proposed in this application is innovative because it will use naturally
heterogeneous populations whose genetic and behavioral conditions are similar to patients with psychiatric
disorders. This project will also integrate omics data with the aid of an emerging clustering algorithm,
topological data analysis (TDA). TDA is robust for noisy and sparse datasets while retaining individual
variations that may be lost using typical dimension-reduction algorithms. This study is significant because it
promises to provide the first insights into the genetic basis of the nutritional plasticity of repetitive behavior,
which will foremost contribute to the future understanding of the neural and cellular responses governed by
nutritional interventions. Furthermore, the knowledge derived from this R01 project will be applied to the
murine system in the future to test if it is translational. The success of this test will support a conserved
pathway among heterogeneous populations in our fish, and between fish and mammals, opening the door to
human application of this knowledge.

Public health relevance
Stereotypic repetitive behaviors that are generally believed to be nonfunctional, are seen in a wide range of vertebrate species in blood glucose-inducing, stress-associated environments, and are reduced under ketosis-related nutritional conditions. Accordingly, this research program has two goals: the short-term goal is to address the genes and their gene co-expression networks associated with repetitive behaviors in an experimental fish model implementing naturalistic heterogeneity in the genome and behaviors. The long- term goal is to reveal the genetic and neural mechanisms of how repetitive behavior is chosen among other voluntary behavior types, particularly in terms of stress-associated and nutritional conditions.